Summer Research Experiences in Cancer Science and Oncology

Project Summary/Abstract
For a student deciding on his or her future career or specialty, a mentored research experience provides
critical insights into the lives of professionals in that field. The intern develops awareness of the
professional practices, masters skills and methods, and, in the majority of cases, is further encouraged to
continue study in that field. Internships in cancer research are increasingly vital to the goal of encouraging
greater numbers of scientists and clinicians to focus on cancer to meet our growing need as our nation's
population ages, complexities of cancer care expand with survivorship and cancer's impact on healthcare
continues to increase. With sixty-six years of experience, the Roswell Park Summer Research Experience
Programs in Oncology and the Cancer Science will continue offering summer internships to rising college
seniors (10-weeks) and rising second-year medical and physician assistant students (8-weeks). Its goals
are to inform students' decisions regarding clinical and research careers, motivate them to pursue cancer
research, and give them essential research and communication skills. Each intern is systematically
matched to a physician or scientist, works in the mentor's clinic or lab, explores the demands of the
profession and work environment, contributes to the ongoing research or clinical operations, and reports on
their results through oral and poster presentations. These internships occur in the unique environment of
an NIH-designated Comprehensive Cancer Center where clinical and research operations are tightly
interwoven within the fabric of translational research. Interns will specifically explore the continuum of
progress across basic, population, translational, and clinical trial research through a relevant supporting co-
curriculum of a didactic lecture series and peer-cross training activities. Professional development
programming supports interns' exploration of facets of cancer careers including opportunities to participate
in community education service-learning. We continue our unique partnership with Howard University (a
leading Historically Black College/University) to provide mentoring to sophomore and junior honors
students in their Directed Reading courses. Roswell Park faculty, post-doctoral trainees, and graduate
students videoconference with their Howard honors students bi-weekly to discuss primary scientific
literature. This pre-internship distance mentorship program allows Howard students to arrive at their
Roswell Park summer internship having already studied the literature from their mentor's research area.
We have expanded internship offerings to nursing undergraduates to develop an appreciation and
understanding of oncology research and clinical trial management and meet the needs of developing a
capacity of oncology nurses versed in research and clinical trial implementation. The success of the
Summer Research Experience Programs will be measured by the degree to which interns are encouraged
to pursue careers involving biomedical research, optimally in the cancer field.

Public health relevance
Project Narrative As older Americans are becoming a larger fraction of our nation's population, the impact of diseases such as cancer, which tends to strike later in life, will likewise increase, thus requiring more cancer healthcare professionals to treat patients and more scientists developing new treatments and cures. Summer internships for college and health professions students are effective in recruiting new generations into professions within the cancer team, and in training them in the clinical and research skills they will need to deliver and improve cancer care. Recruiting minorities into such internships will ensure that our future cancer workforce looks more like the patient populations it serves.